Accelerator for the rapid development of countermeasures targeting drug resistant fungal pathogens

SUMMARY
Invasive fungal infections pose a significant medical challenge, particularly for individuals with compromised
immune systems or other conditions due to HIV, cancer, organ transplantation, diabetes, chronic respiratory
ailments, tuberculosis, COVID-19, and influenza. Prompt diagnosis and effective antifungal treatment are crucial
for positive clinical outcomes. Current antifungal drugs are limited in number and efficacy, and their effectiveness
has been compromised by the emergence of drug-resistant strains, notably Candida auris, Candida glabrata,
and Aspergillus fumigatus. To combat this growing problem, there is an urgent need to develop new drugs
capable of effectively treating invasive infections caused by drug-resistant fungal pathogens. Additionally,
actionable point-of-care diagnostics for Candida bloodstream infections are essential for initiating timely and
appropriate therapy, ultimately reducing overall mortality rates. While efforts from the biopharmaceutical industry
have led to some expansion in the antifungal pipeline, more potent and targeted drugs are urgently required. In
response to these pressing challenges, a Center of Excellence in Translational Research (CETR) focused on
rapid drug and diagnostic development will be established. This Center harnesses expertise of leading academic
and industry professionals, many of whom have a track record of successfully bringing FDA-approved products
to market. The Projects selected encompass a wide range of new and established pharmacological drug targets,
as well as a state-of-the-art diagnostic platform. Among the projects underway, collaborations with
biopharmaceutical partners Prokaryotics and Scynexis are focused on the development of advanced small
molecules targeting key enzymes involved in cell wall biogenesis. Additionally, efforts are underway to develop
an antibody-based immunotherapy to combat drug-resistant infections. Finally, a Project dedicated to creating a
novel point-of-care diagnostic capable of rapidly detecting Candida bloodstream infections in partnership with
Cepheid Diagnostics on the GeneXpert platform, holds promise for revolutionizing the diagnosis and
management of fungal infections. An integrated network of science cores staffed by experienced directors,
facilitate efficient compound optimization and progression through clear ‘go, no-go’ metrics. While all programs
prioritize high-threat drug-resistant Candida species, some drug candidates may also demonstrate efficacy
against azole-resistant Aspergillus fumigatus. In summary, this CETR-based drug and diagnostic development
accelerator represents a concerted effort to address the pressing need for novel treatments and diagnostics for
invasive fungal infections. By leveraging the expertise of industry and world class translational academic
partners, this initiative aims to rapidly advance innovative solutions to combat antifungal drug resistance and
improve clinical outcomes for patients affected by these challenging fungal infections. The anticipated outcome
of our successful efforts will be to create two IND-ready small molecule drug candidates, a lead optimized
novel immunotherapy, and a 510(k) ready point-of-care diagnostic for bloodstream infections.

Public health relevance
NARRATIVE A Center of Excellence in Translational Research (CETR) will be established that confronts the pressing challenge of invasive fungal infections, particularly those resistant to existing treatments, by leveraging academic and industry expertise within a common enterprise. The CETR's mission encompasses the accelerated development of IND-ready small molecule drugs, an enhanced immunotherapy, and a 510(k) ready rapid point- of-care diagnostic tool to address unmet medical needs and advance public health by combating drug-resistant fungal pathogens.